NEURAL SUBSTRATES UNDERLYING BEHAVIOR ORGANIZATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Deterime the basic neural systems important for decision making in healthy volunteers. Develop a basic systems neuroscience endophenotype based on decision-maiking and related processes for anxiety, mood and addictive disorders.